Soluble adenylyl cyclases in pulmonary endothelial permeability

PROJECT SUMMARY
Soluble adenylyl cyclases generate a cAMP signal that breaks down microtubules leading to endothelial cell
barrier disruption. The P. aeruginosa type 3 secretion system effector exoenzyme Y is one such soluble
cyclase. However, we have discovered that this enzyme is a promiscuous nucleotidyl cyclase capable of
generating both purine and pyrimidine (i.e. non-canonical) cyclic nucleotide monophosphates, including cGMP,
cUMP, and cAMP. The cAMP signal, and to a lesser extent the cGMP signal, activates protein kinase A, which
phosphorylates tau leading to microtubule breakdown. Phosphorylated tau accumulates inside the
endothelium for several hours as a high molecular weight, or oligomeric, form, and is then released from the
cell into the supernatant in vitro, and bronchoalveolar lavage and blood in vivo. Preliminary data suggest
cellular release of high molecular weight tau is stimulated by cUMP. Our previously published work and recent
preliminary studies indicate high molecular weight tau retrieved from cellular supernatant fractions is heat
stable, protease resistant, insoluble in certain detergents, insensitive to RNase and DNase treatments, and can
be resolved in a 30-50% ammonium sulfate fraction by column chromatography. It can be sedimented by
centrifugation with an angular momentum of 1.14 x 1012. This high molecular weight tau is transmissible
between cells, leading to inter-endothelial cell gap formation, increased permeability and cytotoxicity;
pulmonary microvascular endothelial cells are especially sensitive to this injury. Its cytotoxicity is inactivated
by phenol extraction, by post-translational modification with diethylpyrocabonate, and with hexafluoro-2-
propanol, all characteristics of amyloid proteins. We have searched for a means to prevent the transmissible
cytotoxicity as an anti-inflammatory therapy. We have recently discovered that prion protein is expressed in
lung endothelium. Whereas prion antibody treatment initiates a pro-survival signal and prevents tau-induced
hyperpermeability and cytotoxicity, prion protein genetic deletion increases endothelial sensitivity to the high
molecular weight tau. Hence, this proposal tests the hypothesis that ExoY generates purine and pyrimidine
cyclic nucleotides in endothelium and induces release of high molecular weight tau capable of generating
transmissible hyperpermeability and cytotoxicity, an effect prevented by antibody ligation of prion protein.

Public health relevance
PROJECT NARRATIVE Endothelial cells line blood vessels and form a barrier that separates blood from tissue. In infection, this endothelial cell barrier is disrupted leading to the accumulation of fluids outside of the blood vessels, which compromises tissue function. Here, we resolve a novel mechanism of endothelial cell injury that perpetuates lung fluid accumulation, and we identify a new target for treatment of this important clinical problem.